Environmental Exposome as a Driver in Alzheimer’s Disease

Project Summary
This project seeks to examine the role of the exposome as a significant risk factor for Alzheimer’s disease (AD) among people living in different communities. This work will utilize blood samples from the 3,000 participants in the ongoing Health & Aging Brain Study (NIA, U19AG078109). This work can lead to strategies to lower environmental exposures in at-risk populations in order to reduce their risk for developing AD.

Public health relevance
Project Narrative Alzheimer's Disease (AD) is the most common cause of dementia, and it disproportionately affects African Americans and Hispanics. Emerging data suggest that the “causal” pathological markers of AD, as defined by the AT(N) framework (Amyloid, Tau, Neurodegeneration) vary by race/ethnicity. The current grant will examine the role of the exposome, and its link to the ATN framework, in the risk of developing AD among the three ethnic groups.